Pancreatic islet alpha cell response to insulin resistance and type 2 diabetes

Type 2 diabetes (T2D) is a chronic disease that affects nearly 25% of U.S. Veterans, a prevalence that
exceeds that among the civilian population, and represents a growing challenge to the VA healthcare system.
T2D comprises a heterogeneous set of metabolic disorders that commonly arises from obesity-associated
insulin resistance, inadequate insulin production and secretion from pancreatic islet beta cells, and
dysregulated (often increased) secretion of glucagon from pancreatic islet alpha cells that collectively lead to
hyperglycemia. Although it has been recognized for decades that diabetes is a bi-hormonal disease reflecting
pathology in both pancreatic islet beta and alpha cells, the mechanisms governing human alpha cell function in
physiological or pathological settings are virtually unknown. Therefore, discovery of molecular mechanisms
that control human alpha cell gene regulation and hormone secretion are urgently needed. Islet-enriched
transcription factors (TF) are critical regulators of alpha and beta cell development and function, with
alterations in their activity leading to diabetes. One such TF, MAFB, was shown to be compromised early on in
human islets in response to diabetes-relevant cellular stressors, including oxidative stress, high fat dietinduced
insulin resistance, and hyperglycemia. Furthermore, both type 1 diabetes and T2D are associated with
marked downregulation of MAFB expression in human alpha and beta cells, implicating compromised MAFB
activity with islet cell dysfunction. I hypothesize that MAFB is a critical regulator in human alpha cells, with its
loss contributing to dysregulated g/ucagon secretion and glucose homeostasis pathophysiologically. To test
this hypothesis, I will use genetic manipulation of MAFB levels in a human pseudoislet system combined with
advanced transplantation, functional, and transcriptomic analyses to determine how loss of MAFB impacts
human alpha cell gene regulation and function in vitro and in vivo (Aim 1 ). In addition, I will comprehensively
define the functional and molecular changes that occur in transplanted human alpha cells in vivo under
conditions of chronic insulin resistance, an acquired pathological state that impacts MAFB (Aim 2). A key
component of my strategy is use of a new transplant-tolerant glucagon knockout mouse model (i.e., GKONSG),
allowing for the first-time longitudinal examination of (patho)physiologic changes in human alpha cells
and glucagon secretion in vivo in response to conditions that mimic the genetic and metabolic milieu of human
T2D. These experiments should provide fundamental new insights into the physiologic and genetic
mechanisms controlling human alpha cell activity in healthy and diseased pancreatic islets and may lead to
new clinically actionable information to treat the underlying causes of T2D. Additionally, the structured training
and mentored research of this career development award will form a strong foundation for my independent
research program as a basic science investigator with the VA Research Service and will facilitate my efforts to
improve the health of Veterans with diabetes.

Public health relevance
Type 2 diabetes (T2D) is a disease that affects nearly one quarter of our nation's Veterans and is a growing challenge to the VA healthcare system. Although the causes of T2D are poorly understood, dysfunctional secretion of insulin and glucagon by pancreatic islet beta and alpha cells, respectively, is a key component. While much emphasis has been placed on studying beta cell biology, very little is known about the mechanisms controlling alpha cells in health or in diabetes. Decreased levels of islet-enriched nuclear factors may contribute to islet dysfunction in T2D. In this grant, we will investigate how loss of one such factor, MAFB, affects the function of human alpha cells. In addition, we will broadly define how alpha cell activity and health are compromised under insulin resistant conditions that mimic the metabolic environment of T2D. We will use new technologies and experimental approaches coupled to in vitro and in vivo analyses to discover physiologic and genetic mechanisms controlling human alpha cell activity in healthy and diseased pancreatic islets.